Texas Occupational Safety and Health Surveillance Program

PROJECT SUMMARY State-based occupational safety and health surveillance systems are essential for tracking occupational exposures, injuries and illnesses, identifying emerging issues and priority/high-risk worker populations for preventive interventions. The Environmental Surveillance and Toxicology Branch (ESTB) at Texas Department of State Health Services (DSHS) requests five years of funding for an Expanded Program under the National Institute for Occupational Safety and Health (NIOSH) State Occupational Safety and Health Surveillance Program. As part of enhanced fundamental program activities, we will collect, analyze and report data for all currently-defined occupational health indicators (OHI) by the Council of State and Territorial Epidemiologists, conduct detailed analysis of OHIs and other state and national datasets. We will also conduct in-depth investigation and case follow-up activities for adult blood lead epidemiology and surveillance (ABLES). DSHS also proposes three expanded projects- 1) acute occupational pesticide poisoning (AOPP) surveillance and prevention, 2) occupational respiratory disease (ORD) surveillance and prevention and 3) enhancing state’s occupational health informatics for emergency preparedness and response. We will continue collaborative- enhancing activities with state and federal partners to conduct interventions for prevention of injuries and illnesses. Improved surveillance, data dissemination and targeted preventive interventions for high-risk, high-priority occupational health issues and conditions will lead to decreased occupational mortality and morbidity, eventually overall improvements in population health.

Public health relevance
PROJECT NARRATIVE States can provide data from case- and population-based surveillance and in-depth investigations of occupational injuries and illnesses and contribute to the national occupational safety health surveillance efforts. These data can help guide targeted intervention efforts to reduce and prevent work-related mortality and morbidity. Given more than 50% of Texas residents are employed, this will lead to overall improvement in population health.